Short Courses for Teaching Gene-Environment Interactions with a focus on Environmental Justice Communities

PROJECT SUMMARY/ABSTRACT
There is a dramatic decline in the US on environmental health education and this is particularly noticeable in the
training of health professionals. This MIT program in collaboration with peer P30 centers at NYU and UNM, will
address health professionals’ need for training in genomics and environmental health with a one-week Short
Course on gene-environment interactions. Two Short Courses will be taught each summer over the grant cycle
with rural Tribal Colleges, serving the Cheyenne River Sioux Tribes (CRST) in South Dakota, and the Nursing
Students at Ramapo College serving the Ramapough Lenape Tribe in New Jersey. Also, an online evening
course will be piloted for working nurses in the Dakotas. Providing such learning opportunities for nurses that
work primarily with Indigenous populations and/or environmental justice communities will significantly contribute
to building community public health in vulnerable populations. Teaching gene-environment interactions requires
foundational familiarity with molecular biology and instructing the course participants on how to communicate
this fundamental knowledge is an important skill learned in this short course. The participants will start each day
with a lecture/discussion on a pre-selected, community-relevant environmental health topic. Lectures will be
followed by a unique hands-on program using MIT-patented DNA and Protein models and pre- and post- tests
will be used to measure participant learning gains. Each topical lecture will reinforce the hands-on molecular
biology sessions, demonstrating specific applications for Environmental Justice Communities. Importantly, the
skills of communicating gene-environmental concepts learned from the MIT Edgerton Center DNA Kit and
Protein Kit to colleagues and community members will be practiced using different skill sets and critiqued during
the short course. Training from these Short Courses will help participants communicate difficult topics including
environmental exposures that cause genetic changes and protein responses. Short Course participants will
develop an expanded skill set to understand and practice gene-environment interactions through examples, and
will generate a health messaging product on a topic of their own choosing in environmental health to demonstrate
skills gained in communication. A follow up study (3 months later) will be conducted to collect feedback on how
participants have utilized their new knowledge about gene-environment interactions and communication skills.
The proposed courses will fill a much-needed gap in health care professional training that has the potential to
bring awareness and enhance quality of life to communities who need it the most.

Public health relevance
PROJECT NARRATIVE This R25 Short Course program will impact public health by teaching environmental health and genetics to nurses and health care professionals serving Indigenous and marginalized populations. Utilizing the courses’ teachings on communication, nurses will translate public health messages to community members. The scientific workforce will also be broadened as the Short Course promotes careers in environmental public health research.